Scientific Cyberinfrastructure Research Program

To accomplish its objectives, the SCI program is divided into key area teams (Key Area Team, KAT) for associated coordination and governance processes that reside within the overall SCI program. Highlights of progress toward objectives and accomplishment of milestones within the current KATs include:
1. Core Key Area (Core): Progress has been made in providing foundational software systems, principally Knime and RStudio Connect, in the development of skills for use of core resources, such as use of the NIEHS high performance compute cluster, and in developing stronger connections to OSC for support.
2. Evidence Informatics Key Area (EI): Major and impactful progress made on automation and improved methods for data extraction, leading to an expansion of these efforts and implementation of these new approaches in DTT as evidenced by publications, software, DTT presentations at national and international meetings.
3. ToxChem Informatics Key Area (TCI): Progress has been made in developing and implementing new models for dose-response modeling, forward toxicokinetics, reverse toxicokinetics, large-scale inferential methods for sparse matrix completion, molecular-to-phenotypic linkage for biomarker identification, and new initiatives using AI (specifically Large Language Models) for toxicological applications.
4. Data Management Key Area (DM): Progress continues in improving and streamlining data management practices, including development and review of NIH data sharing plans, DTT data pipelines that address most DTT data types, development of data dictionary, and development of an integrated data repository.
5. Knowledge Management Key Area (KM): Major progress has been made in annotation, harmonization and integrating data from diverse sources for ICE, the DTT data dictionary, Methods2AOPs, and the Environmental Health Language Collaborative (EHLC).
Progress continues toward tangible components such as tools, applications, libraries, middleware, databases, data sets, hardware systems, ontologies and terminologies, and related training materials and courses that are hosted on public websites. Where appropriate, new developments or significant updates are supported by publications (see Bibliography). In addition, a new process for SCI-PMT portfolio strategic planning and coordinated development has been partially implemented and will continue as the new ORBIT system becomes available.